Weinstein Cardiovascular Development and Regeneration Conference

PROJECT SUMMARY
The aim of this proposal is to support with partial funding the arrangement and execution of the 2025 Weinstein
Cardiovascular Development and Regeneration Conference in Milwaukee, Wisconsin. The Weinstein
Cardiovascular Development and Regeneration Conference originated from a series of annual meetings in
which investigators funded by three separate RFAs on Cardiac Development in 1986, 1988, and 1990 came
together under the direction of Dr. Constance Weinstein and colleagues at the NHLBI. Subsequent to these
initial RFAs, the Weinstein Conference has been maintained for more than 30 years by a community-led
international steering committee independent of any society or organization. Since its inception, the 3-day
Weinstein Conference has been the premier opportunity for basic science and clinical researchers in the field
of cardiovascular development to interact and present novel data and ideas on various traditional and
emerging topics pertinent to cardiogenesis, congenital heart defects, and adult heart disease emanating from
embryonic origins. This meeting is one-of-a-kind for several reasons: first, it is entirely driven entirely by local
and international organizing committees made up of researchers with no affiliation with societies; second, the
collegial environment promotes the dissemination and discussion of innovative, unpublished data, thereby
increasing the impact of the scientific content; and third while the meeting is attended by many of the senior
leaders in the field, the overarching objective of our conference is to promote the professional development of
trainee scientists and early career investigators. Notably, across the 3 days of our conference only two
scientific talks are delivered by invited speakers, the two keynote seminars; all other talks are selected from
abstracts where junior scientists proposing talks on unpublished data are overwhelmingly favored. In this
proposal, financial support is requested for the 2025 Weinstein Conference to be held in Milwaukee. Funds will
specifically be used 1) to supplement registration fees for trainees to keep costs at a minimum and encourage
attendance, and 2) to provide financial assistance in the form of travel awards for under-represented minorities.

Public health relevance
PROJECT NARRATIVE Congenital heart defects and heart disease are among the most widespread and costly health issues in the United States and worldwide. The Weinstein Conference annually brings together clinical and basic scientists from around the world to discuss the latest findings about the underlying causes and potential cures for cardiovascular abnormalities and disease. This proposal seeks support from NIH to partially fund the 2025 Weinstein meeting in Milwaukee, Wisconsin.